Enabling High-Dimensional Flow Cytometry and Extracellular Particle Analysis at MaineHealth Institute for Research

The MaineHealth Institute for Research (MHIR) is dedicated to advancing research capabilities within the
MaineHealth network, comprising twelve hospitals and health facilities across Maine and New Hampshire.
Our funding request focuses on acquisition of the BD FACSymphony A5 SE system, a crucial addition that
will enable high-throughput, high-dimensional flow cytometric analysis of cells and extracellular vesicles.
Our current flow cytometry capabilities are limited to detecting no more than 12 parameters, hindering the
progress of ongoing NIH-funded research projects led by various investigators within MaineHealth.
Moreover, acquiring this instrument will foster collaboration with neighboring institutions like the Roux
Institute at Northeastern University and the University of New England, where comparable capabilities are
lacking. It will create training opportunities for medical students, especially in spectral flow cytometry,
through MHIR's T35 program. Maine Medical Center's commitment to supporting and enhancing core
facilities, especially the Flow Cytometry Core, is evident through substantial financial investments, ongoing
funding support, strategic planning efforts, and a pledge of over $2 million over the next five years to ensure
the continued success of all its core facilities. This dedication reflects the institution's commitment to
fostering cutting-edge biomedical research and sustaining a thriving research ecosystem. The
implementation of high-dimensional flow cytometry will significantly enhance the scope and depth of
biomedical research at MHIR. These projects collectively aim to unravel the complex cellular and molecular
mechanisms involved in various health-related phenomena, spanning from immune responses following
resuscitation after cardiac arrest to the prevention of bone loss in post-menopausal women. The cytometer
enables precise characterization of cell populations and their functional states, facilitating the identification
of key contributors to tissue damage, inflammatory cascades, mitochondrial function, and drug resistance,
thereby deepening our understanding of underlying biological processes and paving the way for developing
novel therapeutic strategies across diverse health conditions. Ultimately, the integration of high-dimensional
flow cytometry enhances the institution's capacity to address complex health challenges and drive
transformative discoveries in biomedical science. In summary, the addition of the BD FACSymphony A5 SE
to MHIR will significantly benefit Maine's research community by driving scientific innovation, attracting
funding, and fostering economic and educational growth. It will elevate research capabilities, support the
development of COBRE projects, empower project leaders to acquire preliminary data for independent
funding, and enhance training opportunities for future scientists. Moreover, it will enhance operational
efficiency and maintain competitiveness in high-dimensional flow cytometry research, ensuring that MHIR
remains at the forefront of biomedical research.

Public health relevance
This research is crucial to public health as it enhances our understanding of complex cellular mechanisms and disease processes, leading to the development of novel therapeutic strategies. By expanding and elevating flow cytometry capabilities at MHIR, more detailed and precise analysis of cell populations is achievable, facilitating advanced research in immune responses, metabolic disorders, and many health conditions. The broader community ultimately benefits from scientific innovation, education of future scientists and doctors, and regional institutional collaborations through discoveries that contribute to improved healthcare.